Advancing Cardiothoracic Surgical Trials in Rural Health Populations

PROJECT SUMMARY
The Cardiothoracic Surgical Trials Network (CTSN) has made significant contributions in advancing the
evidence base for cardiothoracic surgery. As the population ages and the incidence of cardiovascular disease
remains high, there is an important public health need to expand the capacity of the CTSN. Northern New
England (NNE) is home to the most rural and elderly population in the US. Individuals living in NNE are
medically underserved and face significant socioeconomic challenges. These conditions occur in the context of
higher rates of comorbid conditions, leading to a high cardiovascular disease burden and lower life expectancy.
Importantly, rural patients are underrepresented in cardiovascular clinical trials.
As hospitals located in NNE, Dartmouth-Hitchcock Medical Center (DHMC) and Maine Medical Center (MMC)
share a common goal of improving the health of rural communities. Specific aims are: (1) to expand the
capacity of the CTSN in rural populations with high cardiovascular disease burden and develop strategies for
implementing trial findings in such patients; (2) to support the development and clinical research capacity at
MMC; and (3) to train the next generation of implementation science researchers through the Clinical and
Implementation Research Skills Program (CIRSP). Several unique features of this collaboration will allow
achievement of these aims. First, DHMC and MMC are the major referral centers for cardiac surgery in NNE,
ensuring an ideal setting for recruiting patients with a high cardiovascular disease burden. Second, DHMC is
an international leader in the use of regional and national registries to facilitate population-based research.
DHMC is the data coordinating center for Northern New England Cardiovascular Disease Study Group
(NNECDSG) which collects data on 90% of cardiac surgery in NNE. DHMC also maintains the largest non-
federal repository of Medicare data in the US through the Dartmouth Atlas. Third, Dr. Iribarne has 11 years of
experience with the CTSN and brings significant knowledge of lessons learned on optimal recruitment
strategies for enrolling cardiac surgery patients. Fourth, DHMC and MMC have worked collaboratively in
quality improvement since 1987 through the NNECDSG; the Linked Clinical Research Center (LCRC) program
is a natural extension of this collaboration. Fifth, a group of nationally recognized experts in implementation
science has been assembled to educate CIRSP Scholars in late-stage implementation research.
The expected results are that: (1) the capacity of the CTSN will expand into rural populations with high
cardiovascular disease burden; (2) implementation science will be integrated in future CTSN research; (3)
MMC will be a leading enroller in CTSN trials; and (4) early career investigators will be trained in and perform
late-stage implementation research using the CTSN infrastructure. These results will support the mission of the
LCRC program in expanding the capacity of cardiothoracic surgery research in areas of need.

Public health relevance
PROJECT NARRATIVE Rural patients have traditionally been underrepresented in cardiovascular clinical trials yet have a higher burden of cardiovascular disease than patients from metropolitan areas. Thus, there is a significant need to integrate rural patients in clinical trials conducted by the Cardiothoracic Surgical Trials Network. Dartmouth- Hitchcock Medical Center and Maine Medical Center as Linked Clinical Research Centers will expand the capacity of cardiothoracic surgery research in Northern New England and develop strategies to implement research findings to rural communities with a high cardiovascular disease burden.